Schwann Cell Reprogramming after Nerve Injury

Abstract
Myelination of axons in the nervous system is critical for not only conduction of action
potentials, but also for providing tropic support to ensure long term survival of neurons in both
the central and peripheral nervous systems. Myelin disorders are a major cause of
neurological disease, and can be caused by genetic disorders, infectious disease, and
inflammation. The peripheral nervous system has substantial plasticity in being able to
regenerate after nerve injury, and critical transcription factors and their target gene networks
have begun to be elucidated. Schwann cell reprogramming to a new differentiated state is a
critical and rate limiting factor in peripheral nerve regeneration, particularly when regeneration
is impaired as a function of aging/chronic denervation. Therefore, understanding the pathways
that control gene expression reprogramming will provide insight into means by which
remyelination after nerve injury can be accelerated.
The long term objective of our laboratory is to elucidate an integrated mechanism of
Schwann cell reprogramming after nerve injury based on critical transcriptional and
epigenomic switches. We have found that many critical injury genes are associated with
polycomb-associated histone modifications (H3K27me3 and H2AK119ub) prior to injury, and
this proposal focuses on testing how reversal of the polycomb pathway is required for
Schwann cell responses to peripheral nerve injury. We have also found an expected role of
polycomb eraser proteins in myelin homeostasis. Using a variety of techniques established in
our laboratory, we will test for the first time the involvement of modulating PRC1 pathway in
nerve injury responses. In addition, our work has highlighted mechanisms by which Sonic
Hedgehog is activated in repair Schwann cells, and we will employ novel mouse resources to
elucidate the mechanisms and role of Sonic Hedgehog signaling in injured peripheral nerve.

Public health relevance
Project Narrative Schwann cells not only form myelin that is critical for nervous system development, but they also perform several pro-regenerative roles after peripheral nerve injury. This proposal will characterize transcriptional and epigenomic switches required for reprogramming Schwann cells after peripheral nerve injury, and will elucidate the role of hedgehog signaling in nerve injury.